Enabling high-fidelity population voltage imaging with next-generation optical platforms and indicators

Project Summary
Simultaneously monitoring neuronal activity in large populations with single-neuron resolution in
vivo is critical for understanding the mechanisms underlying brain function and the generation of
flexible, adaptive behavior. Genetically encoded voltage indicators (GEVIs) offer a promising
approach for optically capturing electrical membrane potentials, enabling spatially resolved
recordings with genetic specificity. However, both the intrinsic properties and the current limitations
of GEVIs present significant challenges for the design and implementation of optical systems,
particularly of two-photon (2P) imaging systems, that are maximally adapted to GEVIs. These include
their millisecond response times, membrane localization, low brightness, and limited signal-to-noise
ratio (SNR). Consequently, current voltage imaging techniques have been restricted to small neuron
populations, superficial cortical layers, or sparse labeling conditions.
In our previous work on calcium imaging, we demonstrated mesoscale volumetric imaging of up to
one million neurons in the mouse cortex by implementing the Many-fold Axial Multiplexing Module
(MAxiMuM). This project extends that conceptual framework to voltage imaging while incorporating
a novel spike detection algorithm. The proposed optical platform is designed in a principled manner
to deliver a highly optimized 2P multiplexing system that meets the unique requirements of GEVIs in
terms of temporal, spatial, and energy efficiency. This system will drive iterative development of
voltage indicators with tailored kinetics, while its versatility enables efficient in vivo screening and
diverse biological applications. Among its capabilities, the system will allow imaging from fields of
view several hundred microns wide at 750 Hz and depths of ~500 μm. Smaller FOVs will be
achievable at higher speeds (up to 2 kHz) which will enable detection of single spikes within bursts. A
high-sensitivity mode for detecting sub-threshold potentials will also be implemented. By combining
this platform with an innovative excitation strategy and the co-development of advanced GEVIs, we
aim to achieve targeted multi-plane population voltage imaging of large populations of neurons in the
mouse brain.

Public health relevance
Project Narrative Genetically encoded voltage indicators (GEVIs) have recently emerged as powerful optical tools for capturing neuronal electrical activity with genetic specificity in a high-throughput manner, which is critical for understanding how complex brain functions in mammals arise from parallel and distributed neural computations. However, the fast temporal dynamics, low brightness, and limited sensitivity of GEVIs, coupled with a lack optical systems designed in a principled manner based on intrinsic GEVI properties, have prevented the full exploitation of their potential. In this project, we propose an integrated approach that combines the engineering of enhanced GEVIs with the design, implementation, and application of advanced optical imaging technologies.